Project 3: Dissecting the neural and neuromodulatory control mechanisms of arterial dynamics during sleep

Abstract, Project 3
Sleep is accompanied by large changes in neural activity, modulatory state, and hemodynamics. The large
arterial dilations and contractions during sleep could drive perivascular pumping of CSF, which would help clear
fluid and solutes from the brain. We hypothesize that during NREM sleep, the large oscillations of arterial
diameter are driven by local neural activity and coordinated globally across the cortex by noradrenergic (NE) and
cholinergic (ACh) neuromodulatory drive. We will test this idea by optically imaging the cortical vasculature of
sleeping mice while perturbing neural activity and neuromodulation. In Aim 1, we will alter the activity of defined
neuronal populations during sleep using opto-and chemogenetic tools to determine the role of local neural activity
in controlling vascular dynamics. In Aim 2, we will use fluorescent biosensors, optogenetics, and chemogenetics
to understand the role of cholinergic and noradrenergic modulation in coordinating the global cortical vascular
dynamics during sleep. We will measure the temporal relationship between ACh and NE modulation, and dissect
their respective roles in controlling hemodynamics during sleep. In Aim 3, we will use multiplane two-photon
imaging to visualize the directions of propagation of arterial constrictions and dilations and widefield imaging of
neural and vascular signals to visualize how vascular activity is coordinated across multiple spatial scales during
sleep.
Project 3 will contribute to the overall U19 proposal by dissecting the neural mechanisms controlling
arterial dilations and constrictions during NREM sleep. Our measures of arterial dynamics at both the local and
global scales during sleep will provide important data for the modeling in Project 1. Our use of the mouse model
will complement the measurements in Project 2. It will also help bridge the detailed mechanistic studies relating
arterial diameter changes of CSF movement in Project 2 with the other Projects by making corresponding arterial
dynamics measures during sleep. Our determination of causal relationships among neuromodulation, neuronal
subtype activity, and vascular dynamics will be applied to understand the simultaneous EEG and neuroimaging
data in Project 4.